THE STUDY OF IMMUNE ADJUVANTS IN RODENT TUMOR MODELS

This laboratory is involved in defining the in vivo biologic effects of immune enhancing reagents in rodent models. In particular, the administration of interleukin-2 (IL-2), an immunoenhancing lymphokine, is being investigated in murine and rat models to establish rational approaches to the immunotherapy of cancer. The bioavailability, toxicity, immune effects and antitumor effects of IL-2 are being examined in these models. Mechanisms of tumor rejection in a specific adoptive immunotherapy model is being investigated. Requirements for successful adoptive immunotherapy are being defined in this model.